High-Resolution Direct-Conversion X-ray Detectors for Low-Dose Imaging

Project Summary/ Abstract
This project aims to develop and validate high-performance, low-cost direct-conversion X-ray
imaging technology based on perovskite sensors for medical imaging applications. Current X-ray
imaging faces fundamental limitations in achieving both high spatial resolution and detection
efficiency, leading to suboptimal diagnostic accuracy and increased radiation exposure. The
proposed Flat Panel X-ray Imagers (FPXIs) address these challenges through superior X-ray
sensitivity, exceptional spatial resolution, and high contrast-to-noise ratio, enabling enhanced
diagnostic capabilities while reducing patient radiation exposure.
The research objectives include: (1) optimizing perovskite sensor film architecture for uniform
large-area coverage while maintaining high sensitivity-to-dark-current ratios, (2) developing full-
scale detector prototypes, and (3) conducting comprehensive validation studies.
The research methodology combines advanced materials engineering and fabrication techniques,
and systematic evaluation. Key innovations include ultra-high purity material synthesis,
optimized large-area sensor deposition, and novel charge transport architecture. The technology
enables significant radiation dose reduction while improving image quality across various medical
applications including mammography, general radiography, and tomosynthesis.
This development addresses critical healthcare needs by potentially improving early cancer
detection capabilities, reducing radiation exposure risks, and lowering healthcare costs through
more affordable imaging systems. The successful completion will provide healthcare providers
with superior diagnostic tools while enhancing patient safety through reduced radiation exposure.

Public health relevance
Project Narrative This innovative X-ray imaging technology will significantly enhance early disease detection capabilities while reducing radiation exposure risks across millions of patients undergoing medical imaging procedures annually. The development of high-performance, low-cost X-ray detectors will improve diagnostic accuracy in critical applications like mammography, where significant numbers of breast cancers are currently missed during initial screening, while simultaneously reducing the cumulative radiation burden for patients requiring frequent imaging. By making advanced imaging capabilities more accessible through reduced costs, this technology will help democratize access to superior diagnostic tools across healthcare facilities of all sizes, ultimately contributing to improved patient outcomes and reduced healthcare disparities.